Priming the Pump: Training Physician-Scientists in Translational Neuroscience

Abstract (of Parent Award) This proposal aims to continue and improve upon a residency training research track with the explicit goal of recruiting MD/PhD and medical graduates with a track record in conducting research. The program provides early exposure to clinical research to stimulate interest in translational research among our basic science trainees. There are 7 months of exposure to translational research in both inpatient and outpatient clinical research settings, and 14.5 months of protected time for a mentored research project. These months will be augmented by intensive mentoring, overseen by the PIs, functioning as meta-mentors, as well as preceptorships focused on ethics, statistics, research design and principles of translational research. All this will be attained while meeting ACGME requirements so that graduates will be board eligible. We already have early evidence that such a 4-year program permits research track residents to jump start their research career while still residents, rendering them better prepared for research fellowships and the K award process, ultimately leading to careers as independent investigators. Because the program leads to board eligibility, we offer our trainees a no-risk path towards enhanced likelihood of success as independent investigators. This approach is intended to remedy the current state of affairs wherein MD, PhDs often are faced with re-starting their research after a hiatus created by the need for clinical training. We anticipate educating physician-scientists to enhance the pipeline of translational investigators, a key goal of the NIMH.

Public health relevance
We propose to train promising URM medical students in psychiatric research at Columbia University through an eight-week summer program. The key goal is to enhance the probability that scholars will continue to pursue careers in psychiatry and psychiatric research, in order to tackle the vexing scientific challenges facing psychiatry and augment the NIMH “pipeline” of URM investigators. Through targeted mentoring and career development, hands-on research, and formal didactics, we plan to boost the knowledge, confidence, and competence of our scholars to maximize the likelihood that they ultimately pursue research careers within psychiatry.